Applied Research - Project 2

PROJECT SUMMARY
For decades, the mouse has been the premier animal model for studies of human disease, providing
the opportunity to explore experimental questions that are intractable for direct study in humans. As a
result, key insights have been obtained for a variety of clinical conditions. Spurred by advances in
technology and international efforts to systematically knock out all of the protein coding genes in the
genome, the number of genetically engineered mice has expanded rapidly in the past 20 years. The
responsibility for maintenance and distribution of mutant mice was initially placed on individual
investigators, which was a tremendous burden in terms of cost, labor and space. In 1999, the NIH
recognized the need for a resource to protect the investment in mutant mouse strains and ensure open
access to all biomedical researchers and established the Mutant Mouse Regional Resource Centers
(MMRRC). Since 1999, the central goal of the MMRRC-UNC has been to work collectively with
MMRRC consortium partners to develop and maintain high standards for importation, rederivation,
cryopreservation, and distribution of mutant mouse strains to biomedical investigators. The MMRRC-
UNC will continue to contribute to the goals of the Consortium in the next project period by
implementing the following Specific Aims devoted to continuing its successful role as a cryoarchive and
distribution center and incorporating research goals that synergize with and extend the value of the
resource: 1) Streamline and improve operating procedures to increase importation, distribution, and
cryoarchive of mouse strains. 2) Establish, maintain, and distribute a comprehensive cryoarchive for the
Collaborative Cross (CC) resource. 3) Develop and disseminate computational tools for mouse genetic
QC and genomics research, which will enhance phenotypic reproducibility. 4) Investigate the interaction
of genetics and environment on experimental variability and reproducibility.
!

Public health relevance
Project Narrative (Research)- do not complete according to PAR-19-175.